IGF::OT::IGF Digital Marker of Marijuana Intoxication: Measure of Dysfunctional Retinal Ganglion Cell Response. N43DA-18-1221

Under this Small Business Innovation Research (SBIR) Phase I project, Research Topic 163, the Contractor will develop a portable, easily applied system incorporating a neuropsychological test protocol to detect cannabis impairment.